Trauma informed care

PROJECT SUMMARY
The high prevalence and associated negative impact of trauma on the mental and physical health of people living
with HIV and their engagement in HIV care (i.e., retention, viral suppression) underscore the need for
systematically addressing trauma within primary HIV care. Trauma-informed care (TIC) is an evidence-based
treatment framework that involves understanding, recognizing, and responding to the effects of trauma. Evidence
from other settings demonstrates that TIC improves patient outcomes, increases staff morale, and is cost-
effective. In recent years, WHO, HRSA, and NIH have called for trauma-informed HIV systems, yet limited
research exists on the strategies needed to facilitate TIC implementation in HIV care settings. In a pre-
implementation study to assess TIC provision and factors influencing adoption and implementation of TIC in
Ryan White-funded HIV Clinics (RWCs) at the epicenter of the US HIV epidemic (DHHS Region IV), we found
that most providers/staff felt that TIC was appropriate for RWCs and had some trauma screening and referral
protocols in place, but training on trauma and methods for working with trauma survivors and lack of staff support
for managing the emotional toll of working with trauma survivors were salient factors limiting TIC adoption.
Importantly, TIC training and use of an implementation advisor (herein called implementation facilitation) were
identified as potential strategies for facilitating TIC implementation in RWCs, including implementation of staff
support. Guided by the Interactive Systems Framework, our Emory team with expertise in TIC will work in
collaboration with The Emory Centers for Public Health Training and Technical Assistance (Emory Centers) and
RWCs to develop and pilot test two implementation strategies (TIC training and facilitation (of TI-staff support
practices, e.g. debriefings, selfcare, etc.)) on provider- and clinic-level implementation and patient effectiveness
outcomes. The aims include: 1) to develop trauma-informed HIV care trainings and an implementation facilitation
process to tailor staff support practices to clinic-specific needs, with iterative feedback via theater testing
methodology with RWC staff/providers/administrators to inform content, dose, intensity and delivery to optimize
effectiveness for RWCs; 2) to refine the two implementation strategies developed in Aim 1 using a modified
Delphi method to build consensus on content and delivery with RWC stakeholders across the DHHS Region IV
to optimize use across a diversity of RWCs; and 3) to pilot and perform a mixed-methods evaluation of the
preliminary effectiveness of the refined implementation strategies on provider- and clinic-level implementation
outcomes at two high-volume RWCs in Metro Atlanta. The results of this study will inform a future Hybrid Type
2 effectiveness-implementation trial examining the impact of centralized delivery of TIC training and facilitation
on TIC implementation and patient HIV effectiveness outcomes and enable an evidence-driven response to the
high-level calls for integration of TIC into HIV primary care services.

Public health relevance
PROJECT NARRATIVE The high prevalence and associated negative impact of trauma (i.e. child abuse, intimate partner violence) on the mental and physical health of people living with HIV and their engagement in HIV care underscore the need for systematically addressing trauma within HIV services. Trauma-informed Care (TIC) is an organizational structure and treatment framework that involves understanding, recognizing, and responding to the effects of trauma, and has shown promise in impacting the mental and physical health of patients and their care providers in non-HIV settings; however, limited published literature exists about methods for and the effectiveness of integrating TIC within HIV primary care (TI-HIV care). Responsive to our prior pre-implementation study that demonstrated critical gaps in staff TIC training and support in TIC provision across Ryan White-funded HIV Clinics (RWCs) in the Southeastern US, the proposed study develops and pilots culturally- and contextually- tailored TI-HIV care trainings and TIC implementation facilitation processes and examines their preliminary effectiveness on provider and clinic-level outcomes at two high-volume RWCs in Metro Atlanta.